Characterization of the metastatic TIME by subcellular spatial profiling

Increased macrophage infiltration is associated with poorest outcome following neoadjuvant chemotherapy
(CTX) in patients with triple negative breast cancer (TNBC). In contrast patients with increased tumor infiltrating
lymphocytes (TILs) and fewer macrophages achieve a favorable pathological complete response (pCR). In the
metastatic setting macrophages continue to accumulate to promote tumor survival and play a key role in
therapeutic resistance. In order to understand the synergism between macrophages and tumor cells within the
Tumor Immune Microenvironment (TIME), it is essential to have appropriate immunocompetent preclinical TNBC
models that represent the high Epithelial-to-Mesenchymal (EMT)/ Macrophage phenotype observed in patients
with a poor prognosis. We have developed and extensively characterized several genetically engineered mouse
models that lack the p53 tumor suppressor gene that is most frequently lost or mutated in TNBC. These “claudin
low” models closely phenocopy the high EMT/macrophage subtype observed in patients. However, because
metastasis is the cause of mortality in the vast majority of TNBC patients, the critical question remains of whether
macrophage targeted therapies can alter the TIME leading to long-term antitumor immunity in lung and liver
metastases. Therefore, we hypothesize that therapeutic pressures applied on tumor and immune cells cause
alterations to the TIME of lung and liver metastases generating subclonal populations that can lead to resistance
and recurrence via the presence of Intratumoral Heterogeneity (ITH). We propose to spatially profile the
metastatic TIME of lung and liver metastases following, anti-CSF1R (SNDX-ms6352) with CTX and newly
approved anti-PD1 in order to identify mechanisms of resistance that lead to ITH. Further we will explore if
targeting existing metastasis can recruit TILs including antigen presenting dendritic, B and T cells and convert
“cold” tumors “hot” leading to a durable antitumor long-term response. To perform these studies we will directly
introduce unlabeled tumor cells into the lung via tail vein injection or into the liver via the portal vein. Mice will be
randomized and administered 4 weekly treatments of CTX with anti-CSF1R and anti-PD1. BrdU will be injected
to detect lung and liver metastases. Spatial transcriptomics, Imaging mass cytometry, single cell RNA-
sequencing, and flow cytometry, will be utilized to confirm macrophage depletion and study mechanisms of
resistance within the metastatic TIME. Characterization of the lung and liver TIME in these preclinical models
will be compared to results from matched metastasis in the AURORA clinical trial. We will then interrogate newly
identified signaling mechanisms via genetic manipulation (RNAi and CRISPR) and potential small molecule
inhibitors and analyze downstream signaling pathways by immunoblotting and qPCR. Novel gene signatures
observed will be used to identify potential resistant human breast cancer cell lines in order to study signaling
mechanisms in vitro. Our preliminary results demonstrate that targeting macrophages enhances chemotherapy
and ICB efficacy in treating established lung metastasis via the activation of the TIME.

Public health relevance
Patients diagnosed with metastatic breast cancer have limited treatment options, are more prone to develop resistance and are associated with high mortality. Using state of the art spatial technologies we will profile the genes and proteins of responders and non-responders following chemotherapy with macrophage targeting therapy and newly approved T cell activating agents. In order to identify new vulnerabilities that may overcome resistance.